Molecular Basis of Pathogenic Cascades in ALS/FTD Initiated from C9orf72 Hexanucleotide Repeat Expansion

Project Summary
Nucleotide repeat elements, including microsatellites or short tandem repeats, are
common in eukaryotic genomes. Expansions of short nucleotide repeats have been linked to
over 50 different types of genetic disorders, primarily neurological and neuromuscular disorders.
Our understanding of how these repeat elements in the human genome cause diseases is still
in its infancy. A hexanucleotide repeat expansion in a noncoding region of the C9orf72 gene has
been linked to the neurodegenerative diseases amyotrophic lateral sclerosis (ALS) and
frontotemporal dementia (FTD). ALS is characterized by loss of motor neurons, and the C9orf72
hexanucleotide repeat expansion represents the most common genetic cause of both familial
and sporadic ALS. FTD is characterized by degeneration of the frontal and temporal lobes of the
brain and is the second-most common type of dementia in people older than 65; the C9orf72
hexanucleotide repeat expansion is also the most common genetic cause of FTD. This repeat
expansion is also found to contribute to Alzheimer’s disease and Huntington’s disease. To help
relieve the public health burden associated with these diseases, it is important to understand the
mechanisms underlying their pathogenesis. Multiple hypotheses exist to explain the pathogenic
mechanisms underlying C9orf72-linked ALS/FTD. The goal of the proposed project is to
elucidate novel mechanisms through which the C9orf72 hexanucleotide repeat expansion leads
to molecular defects and neuronal toxicity, focusing on gain-of-function mechanisms. The
specific aims are to identify previously unknown pathogenic cascades initiated by the C9orf72
hexanucleotide repeat expansion. These novel pathogenic cascades include, but are not limited
to, RNA toxicity and non-canonical translation products resulting from the C9orf72
hexanucleotide repeat expansion. We propose a series of fundamental studies that combine
biochemical, molecular, and genetic approaches to shed light on the novel pathways leading to
ALS/FTD pathogenesis and to identify potential intervention strategies. Successful completion
of the project is expected to provide insights into fundamental mechanisms of
neurodegeneration in ALS/FTD that may ultimately lead to novel approaches for treating
ALS/FTD and other relevant neurodegenerative diseases.

Public health relevance
Project Narrative An expansion of a sequence of six DNA bases in the C9orf72 gene is the most common genetic cause for neurodegenerative diseases amyotrophic lateral sclerosis (ALS) and frontotemporal dementia (FTD), and the same mutation has been associated with other neurological diseases. Although these diseases are becoming an increasingly relevant public health challenge in our aging society, the mechanisms underlying most of these neurodegenerative conditions remain poorly understood. The biochemical, molecular, and genetic studies outlined in this proposal could lead to novel therapeutic interventions for these neurodegenerative diseases, for which effective treatments are still lacking.